CANCER CENTER SUPPORT (COMPREHENSIVE)

This grant provides support for the broad range of research at the University of Wisconsin Clinical Cancer Center. Senior leaders, program leaders and external advisors provide continuing direction and evaluation of the overall program and shared resources. During the -14 year the objectives remain unchanged. Specific aims include 1) strengthening cancer control research through collaboration with community hospitals, major health care providers and agencies in the state; 2) encouraging research in radiation oncology; 3) strengthening laboratory and clinical programs in cancer prevention; 4) enhancing strong programs in immuno-biology and breast cancer through new research initiatives; and 5) increasing clinical and laboratory research directed toward improved application of cytotoxic anticancer drugs.